Developing the Long Term Care Data Cooperative's Capacity to Monitor Nursing Home Based Infectious Disease Outbreaks

CDC SUPPLEMENT TO LONG TERM CARE DATA COOPERATIVE
The NIA IMPACT Collaboratory COVID related supplement that funded the Long Term
Care Data Cooperative [U54AG063546-02S6] established a cooperative that is compiling
a centralized repository of nursing home electronic medical record (EMR) data from three
different EMR vendors. Numerous nursing home companies using one of these three
vendors have signed up as members, authorizing their EMR vendor to transfer clinically
relevant data, complete with identifiers, to a centralized repository operating under the
auspices of the American Health Care Association (AHCA) a membership association of
most US nursing homes. In addition to the regulatory required Minimum Data Set
information, EMR data being consolidated include all prevalent and incident diagnoses,
orders, medication administration records, change of condition records, daily vital signs,
incident reports, vaccinations, behavior tracking, daily changes in cognitive and physical
functioning, and for some facilities, laboratory and diagnostic test results.
To facilitate use of these data for the purpose of conducting public health surveillance, in
close collaboration with leadership and research analysts at the Centers for Disease
Control and Prevention, Brown University investigators propose to investigate the
feasibility of electronically extracting and validating antimicrobial use data elements from
long-term care (LTC) facility electronic health record (EHR) data and to calculate
numerators and denominators for standardized reporting of antimicrobial use metrics at
the resident and facility level. To further investigate the validity of infection data in the
nursing home EMRs we propose to explore the viability of using the EMR data to identify
additional infectious conditions, which will be selected in consultation with CDC officials,
among nursing home residents. In addition, provide access to and technical support for
analysts from the Centers for Disease Control (CDC) who will conduct additional analyses
of the EMR data in the LTC Data Cooperative.

Public health relevance
Project Narrative As an early step in facilitating use of data assembled in the Long Term Care Data Cooperative under the goal of conducting public health surveillance, Brown University investigators propose to investigate the viability and validity of these EMR data in identifying the incidence and prevalence of selected infectious conditions among nursing home residents that would be accomplished in close collaboration with leadership and research analysts at the Centers for Disease Control and Prevention: .